Defining the regulation of mitochondrial bioenergetics during virus infection

PROJECT SUMMARY/ABSTRACT.
Human cytomegalovirus (HCMV) is a ß-herpesvirus that infects over 50% of the world’s population and
establishes lifelong infection in individuals. HCMV infection is a major concern in individuals with impaired or
naïve immune systems, as it can lead to a range of diseases, including deafness, respiratory disease, and organ
failure. Additionally, HCMV has garnered increased interest in recent years due to its implication in the
emergence and progression of chronic diseases, such as cardiovascular disease and cancer. A striking feature
of HCMV infection is the global rewiring of cellular metabolism for the increased production of biosynthetic
precursors and energy for replication. The dysregulation of cellular metabolism during HCMV infection is
necessary for its replication and has been linked to many of its pathologies, including its oncomodulatory
capacity. However, we currently lack an understanding of the mechanisms underlying the metabolic alterations
observed during infection. We recently discovered that the mitochondrial enzyme sirtuin 4 (SIRT4) is a potent
antiviral factor during HCMV infection. Furthermore, we established SIRT4 as the first known mammalian cellular
lipoamidase, removing the essential posttranslational modification lipoylation from the pyruvate dehydrogenase
complex. This discovery points to SIRT4 as a critical regulator of cellular metabolism, but how SIRT4 exerts its
antiviral function remains unknown. I hypothesize that SIRT4 functions in host defense during HCMV infection
by opposing viral-induced changes in cellular metabolism. Further supporting the critical role of SIRT4 in antiviral
response, I discovered that HCMV has acquired a mechanism to suppress its functions. My preliminary results
demonstrate that SIRT4 is targeted for inhibition by the previously uncharacterized viral protein, pUL13. In my
proposal, I will address both sides of this virus-host interplay. In Aim 1, a combination of molecular virology,
microscopy, proteomics and metabolomics will be used to define SIRT4-mediated mechanisms of defense
against HCMV infection. I will determine which specific SIRT4 enzymatic activities are required for antiviral
response. In Aim 2, I will uncover how pUL13 inhibits SIRT4, as well as characterize its function in regulating
cellular metabolism and mitochondrial bioenergetics. As a long-term objective, elucidating the functional
interaction between SIRT4 and pUL13 can help explain how HCMV induces metabolic changes that promote
disease. This knowledge can point to therapeutic targets for restoring metabolic health and for treating HCMV-
linked pathologies. This research will take place in the Molecular Biology Department of Princeton University, a
program known for its multidisciplinary research and supportive environment for graduate student training and
career development.

Public health relevance
PROJECT NARRATIVE Human cytomegalovirus (HCMV) infection can result in serious diseases in immunocompromised individuals, is the leading infectious cause of congenital birth defects, and is linked to the development of chronic illnesses including cardiovascular disease and cancer. We have discovered that the mitochondrial sirtuin 4 (SIRT4) is a lipoamidase enzyme critical for the regulation of cellular metabolism, and that it exerts potent antiviral activity against HCMV. We propose to investigate the mechanisms of SIRT4 antiviral function, as well as the virus suppression of SIRT4-mediated host defense via the previously uncharacterized HCMV protein pUL13, with the ultimate goal of understanding HCMV-driven pathologies and uncovering novel therapeutic targets.